Population-level interventions and community environment effects on obesity among diverse Asian American ethnic subgroups

PROJECT SUMMARY
Childhood obesity prevalence keeps rising, especially among school-age children, and varies by race/ethnicity.
Children of origins in Asia and the Pacific Islands (Asian/PI), as a whole, have lower obesity prevalence; but, at
lower BMI levels, they have higher risk of obesity-related diseases relative to White peers. Asian/PI children
have remained largely invisible in obesity prevention efforts, though obesity prevalence varies widely among
Asian/PI subgroups, the fastest growing demographic group. Data scarcity is a significant barrier to the design
of strategies to prevent obesity and reduce disparities among Asian/PI. Nutrition policies—those that regulate
the nutritional content of foods and beverages in schools, including the so-called “competitive” foods sold
separately from school meals—could play a key role in the primary prevention of obesity and related chronic
diseases among Asian/PI subgroups. The community food environment near schools can also influence
obesity (e.g., through children’s access, purchases and consumption of unhealthy foods). No studies have
examined the combined influences of multiple nutrition policies and community food environments on child
obesity and disparities among Asian/PI children. Using unprecedented, longitudinal BMI data on >1 million
Asian/PI children disaggregated by ethnicities (Indian, Cambodian, Chinese, Filipino, Guamanian,
Japanese, Korean, Laotian, Native Hawaiian, Samoan and Vietnamese), this quasi-experimental study
responds to the NIH Obesity Strategic Plan by evaluating policy and environmental effects on obesity
disparities. The first of its kind, this longitudinal study will: (1) determine the effects of federal and state
nutrition policies designed to improve food and beverages in schools on obesity disparities among a wide
range of Asian/PI ethnic groups; and (2) investigate how community food environments modify the effect
nutrition policies on obesity disparities. To obtain robust inferences, the study uses the best available
methods to evaluate non-randomized exposures: interrupted time series design and difference-in-
difference analysis to improve causal inferences. The study’s powerful design links longitudinal BMI measures
of diverse Asian/PI children with time-varying measures of the community food environments of all the
public schools to which children attended. Expected results: This study will: (i) strengthen the evidence base
by elucidating the causal effects large scale nutrition interventions on obesity disparities among Asian/PI ethnic
subgroups; (ii) identify nutrition environments near schools where nutrition policies are most effective; and (iii)
illuminate environments (inside and/or near schools) where additional interventions are needed. The study
results have potential to inform strategies focused on two major public health goals—prevent child obesity and
reduce disparities among severely understudied, yet fastest growing Asian/PI populations.

Public health relevance
PROJECT NARRATIVE/ PUBLIC HEALTH RELEVANCE STATEMENT This quasi-experimental, longitudinal study will (a) examine the influence of state and federal nutrition policy interventions for schools on child obesity prevalence and related disparities among diverse Asian/PI subgroups; and (b) determine the extent to which community food environments modify the policy influences on obesity. The study will generate new evidence on the effectiveness of current nutrition policy interventions to prevent obesity among population groups who have been severely understudied in obesity prevention research. Findings from this study will inform population-wide strategies to prevent obesity and promote children’s healthy body weight among diverse Asian/PI populations.